Regulation and Function of Human Polyomavirus circular RNAs

An increasing number of circular RNAs (circRNAs) have been found to be expressed by both viruses and
human host cells during viral infection, yet the physiological significance of most circRNAs remains unclear.
Our long-term goal is to use human polyomaviruses (HPyVs) to understand the regulation and function of
circRNAs and to leverage this knowledge towards developing new diagnostics and treatments for viral
diseases. We propose that many viral circRNAs function as coding RNAs that have distinct properties from
linear RNAs spliced from the same gene. Specifically, our central hypothesis is that Merkel cell
polyomavirus and trichodysplasia spinulosa polyomavirus encodes circular ALTO RNAs, circALTOs, that
are translated to ALTO, which then modulates transcription in infected host cells. This model is based on
preliminary studies showing that both MCPyV and TSPyV early regions efficiently generate circALTO, which
are translated into ALTO protein in vitro. MCPyV circALTO functions as a transcriptional transactivator that
can induce the transcription of multiple genes and pathways that have previously been implicated in DNA
virus infections. We further demonstrate that a miRNA expressed from the MCPyV early region, miR-M1,
negatively regulates circALTO and ALTO levels. Extending and validating this model would represent a
ground-breaking advance in our understanding of circRNA function and regulation. This proposal will be
organized into two aims: 1) Identify the factors that regulate the formation of MCPyV circALTO and its
inhibition by the MCPyV miR-M1 miRNA and determine how these factors impact viral replication and
persistence; 2) Determine how MCPyV ALTO modulates host cell transcription and whether ALTO’s effects
on transcription are conserved in TSPyV. We will collaborate with virologists with expertise in
polyomaviruses and miRNA biology to complete the proposed aims. Completion of this proposal will not
only expand the relevance of circRNAs in virology and cell signaling but also significantly advance our
understanding of the pathogenesis of human polyomaviruses.

Public health relevance
Human polyomaviruses cause a number of devastating diseases, including Merkel cell carcinoma and trichodysplasia spinulosa. Our preliminary studies have revealed that thes polyomaviruses produce circular ribonucleic acid (RNA) “messenger” molecules, which can be detected in affected patient tissues. This proposal explores how these circular RNAs are regulated and how they may function to promote viral diseases.